Core B: Biorepository Core

CORE B ABSTRACT
The Biorepository Core has created a state-of-the-art and internationally competitive infrastructure for optimal
management and oversight of human biospecimens to support the goals of the Center for Molecular
Epidemiology. Biospecimens are the basis of the molecular characterization of both a disease and its host, and
are crucial for modern molecular epidemiologic study. Careful handling of biologic samples with well-integrated
de-identified specimen coding, tracking and data systems are thereby essential for applying cutting edge
technologies to rapidly advance our understanding of the molecular basis of complex disease interactions. In
Phase I of our Center, the Biorepository Core efficiently collected, processed, and aliquoted over 115,000
samples from over 21,000 unique and varied biospecimens by implementing robotic paired with manually
triaged systems. A CLIA certified component of the Core occupying space renovated in our Phase I COBRE in
the new Williamson Translational Research Building now is complete with charge back systems. We further
constructed a secure, off-site Biospecimen Resource Facility to store our high quality samples for long-term
access and future use. Building on our success in Phase I, we will expand our repertoire of centralized
services and volume of samples while preserving rigorous collection, processing and analytic preparation
(including nucleic acid extraction) standards for current and downstream analyses. A growing team of
established investigators with multidisciplinary experience will provide education, training, consultation, and
specialized expertise to the Center. We will enhance our interactive web-based databases and make them
more widely available, and design integrated searchable platforms with linkages to clinical and epidemiologic
data. In Phase II we will refine and phase-in charge back systems to accelerate our trajectory towards
sustainablility and expand utilization of our unique Core resources to other IDeA programs and large-scaled
regional, national, and international initiatives. Thus, we established a new coordinated, centralized
Biorepository infrastructure that will continue to facilitate the scientific advancements of the Center research
projects, and make significant contributions to cross-disciplinary translational research collaborations from the
broader scientific community.